Project ANCHOR: A Small-Scale Pilot RCT of a Supportive Care Intervention for Caregivers of Patients Awaiting Transplantation

SUMMARY
Annually, over 800,000 individuals provide unpaid support to patients with end-stage kidney disease (ESKD),
such as care coordination, activities of daily living, nursing tasks, and emotional support. Much like caregivers
of patients with other life-limiting illnesses, ESKD caregivers experience psychological distress and adverse
health outcomes, including cardiovascular disease and poor self-rated health. This is problematic, because
lack of adequate caregiver support is associated with poor patient outcomes. One of the largest inflection
points for both patients and their caregivers along the treatment continuum for ESKD is listing for kidney
transplantation. However, this process is fraught with uncertainty, ranging from timing of organ offers to post-
transplant risk of infection and graft failure. To our knowledge, no interventions exist to address the needs of
caregivers facing kidney transplantation. To address this gap, my interdisciplinary mentoring team and I have
developed an intervention called Project ANCHOR (Addressing the Needs of Caregivers to Help Optimize
Resilience), based conceptually on the Windle and Bennett framework for resilience in the context of
caregiving and on prior evidence-based interventions. Project ANCHOR employs a telehealth coaching
approach to provide supportive care to family caregivers of patients awaiting kidney transplantation, consisting
of six weekly sessions and monthly follow-up led by a trained lay coach. Content includes management of
kidney disease, skills for coping with stress, ensuring effective social support, improving self-care, and
planning for the future. The overall goal of this exploratory sequential mixed methods research study is to
conduct a formative intervention adaptation and a small-scale pilot randomized controlled trial of a supportive
care intervention for family caregivers of patients listed for transplantation. We will assemble an advisory group
of patients, caregivers, transplant providers, and lay navigators to elicit feedback on the design,
implementation, and results of Project ANCHOR using focus groups and qualitative formative evaluation
interviews. The newly tailored intervention will then be tested for feasibility, acceptability, and potential efficacy
in a small scale RCT vs. standard-of-care for 60 caregivers, allowing us to 1) to assess instruments and
observed differences between the intervention and standard-of-care group; 2) to collect pilot data to evaluate
the RCT design to prepare for a larger intervention study in the future, and 3) to identify strategies to recruit
and retain participants. Results from this study will allow us to provide tailored support to family caregivers of
patients awaiting transplantation and reduce caregiver burden, improve post-transplant outcomes by providing
tools and resources to mitigate caregiver burden, and improve informed consent for caregivers considering
living donation.

Public health relevance
NARRATIVE Family caregivers are an important source of support for patients with end-stage kidney disease, and opportunities exist to enhance caregiver resilience and improve outcomes for both the care partner and recipient. Project ANCHOR (Addressing the Needs of Caregivers to Help Optimize Resilience) will be the first intervention of its kind to address the financial, physical, and mental health burden associated with caregiving for patients awaiting kidney transplantation and will allow us to provide tailored support to reduce caregiver burden, improve post-transplant outcomes by providing tools and resources to mitigate caregiver burden, and improve informed consent for caregivers considering living donation.